A generalizable deep learning platform for unifying quantification of experimental autoimmune uveitis

Posterior uveitis accounts for up to 15% of severe visual impairments in the United States. Mostly affecting
individuals in childhood or young adulthood, uveitis is comparable to diabetes and macular degeneration in
terms of years of visual morbidity. The disease etiology is largely unknown. Experimental autoimmune uveitis
(EAU) is an animal disease that shares essential pathological features with human uveitis and is a valuable
model for studying mechanisms of human uveitis and for evaluating efficacy of new therapies and diagnostic
methodologies. However, a significant limitation with the experimental models including EAU is that
assessment and evaluation of the disease and its severity is subject to substantial inter- and intra-observer
variability and results from lab to lab are rarely reproducible. This shortcoming directly impacts quantification
and accurate assessment of disease, which in turn is crucial for assessing new medical therapies.
Artificial Intelligence (AI) has shown promising applications in ophthalmology and many deep learning models
have been successfully applied to the screening and diagnosis of a growing list of clinical ocular conditions.
Yet, AI models, such as deep learning algorithms, have not been extensively studied in experimental research
such as EAU. We hypothesize that emerging foundation AI models based on self-supervised learning and
vision transformer units will be able to provide a robust generalizable platform for experimental research thus
improve the objectivity and reproducibility as well as accuracy of quantification and disease assessment. The
overarching aim of this study is to provide AI platforms to unify experimental disease assessment with an
application on EAU.
We propose to 1) generate high-quality and well-annotated multi-modal datasets from three independent
centers with fundus, optical coherence tomography (OCT), histological, and immunohistochemical images from
EAU models and 2) develop a foundation model based on emerging AI models to quantify and assess uveitis
images with potential generalization to other experimental diseases. We will validate the AI models using
independent subsets of images to assure reproducibility and generalizability. To achieve these objectives, we
have assembled a team of experts with integrated and complementary skills in uveitis, imaging, and AI with
access to large multi-modal uveitis datasets generated previously at NIH and two other institutes in New
Zealand and UK. We will publish datasets at TVST or Ophthalmology Science journals and make datasets and
annotations publicly accessible to the community. We will also publish AI tools and make them publicly
accessible to the vision community based on the NEI guidelines.

Public health relevance
Posterior uveitis accounts for up to 15% of all severe visual severe handicaps in the US and, experimental autoimmune uveitis (EAU) is an animal disease that shares essential pathological features with human uveitis and is widely used as the animal model for uveitis. Our proposal will generate a foundation artificial intelligence (AI) model based on self-supervised learning and vision transformer (ViT) in order to quantify and unify experimental research such as EAU, a n d we will also generate high-quality annotated datasets with fundus and optical coherence tomography (OCT) images of EAU models from multiple centers. Efforts will generate solid generalizable AI models with reproducible and replicable outcomes in EAU and potentially other animal diseases as well as multi-modal annotated datasets critically needed for AI development a n d , findings may facilitate translation to clinical practice and lead to new treatments for saving vision.